Liver-Enriched Transcription Factors

Role of HNF4α in control of bile acid synthesis and conjugation. Among the many interesting phenotypes in the HNF4α liver null mice (HNF4αdeltaL) is an elevation in serum bile acids. HNF4αdeltaL mice have markedly increased levels of serum bile acids (BAs) compared with control floxed mice (HNF4αF/F). Because bile acids are produced from cholesterol in liver and many enzymes involved in their biosynthesis are preferentially expressed in liver, the role of HNF4α in BA production was examined. This is due in part to the downregulation of genes encoding oxysterol 7α-hydroxylase (CYP7A1), sterol 12α-hydroxylase (CYP8B1), and sterol carrier protein x. CYP7A1 mRNA and protein were diminished only during the dark cycle in HNF4αdeltaL mice, whereas expression in the light cycle was not different between HNF4αdeltaL and HNF4αF/F mice. CYP8B1 mRNA and enzyme activity was reduced regardless of light or dark cycle. An HNF4α binding site was found in the mouse Cyp8b1 promoter that was able to direct HNF4α-dependent transcription. Surprisingly, cholic acid-derived BAs, produced as a result of CYP8B1 activity, were still observed in the serum and gallbladder of these mice. These studies reveal that HNF4α plays a central role in BA homeostasis by regulation of genes involved in BA biosynthesis, including hydroxylation and side chain β-oxidation of cholesterol in vivo.HNF4αdeltaL mice also exhibited decreased expression of the very long chain acyl-CoA synthase-related gene (VLACSR), also called bile acid-CoA ligase, and bile acid-CoA:amino acid N-acyltransferase (BAT). This was associated with markedly elevated levels of unconjugated and glycine-conjugated bile acids in gallbladder of the HNF4αdeltaL mice. In agreement with this in vivo finding, HNF4α was also found to bind directly to the mouse VLACSR and BAT gene promoters, and the promoter activities were dependent on HNF4α-binding sites and HNF4α expression by direct regulation of VLACSR and BAT in vivo. These studies indicate HNF4α plays a central role in bile acid synthesis and conjugation and explain why the HNF4αdeltaL mice have abnormal bile acid homeostasis.Other genes controlled by HNF4α. A number of other genes are controlled by HNF4α as revealed by their down-regulation in HNF4αdeltaL mice. These include the genes encoding blood coagulation factors FXII and FXIIIB, UDP-glucuronosyltransferase 1A9, and proline oxidase, uridine phosphorylase. These genes were also shown to have functional HNF4α binding sties. In the pancreatic β-cells, HNF4α was shown to influence the expression of the K(ATP) channel activity thus explaining in part its association with maturity onset diabetes of the young, type 1 (MODY1).